EFFECTS OF CAPTOPRIL ON PROGRESSIVE TYPE I DIABETIC RENAL DISEASE

Change in GFR and urine protein excretion in end stage renal disease after treatment with an angiotensin converting enzyme inhibitor.